National Succinate Dehydrogenase-deficient GIST Translational Research and Clinical Trial Consortium

PROJECT SUMMARY/ABSTRACT
Gastrointestinal stromal tumor (GIST) is often effectively treated with FDA-approved first-line therapies such as
imatinib and avapritinib. However, this strategy is ineffective in a particular subset of GIST patients—those with
a GIST caused by inherited loss-of-function mutations or sporadic epigenetic silencing of genes encoding the
succinate dehydrogenase (SDH) complex. These SDH-deficient (SDH-def) GISTs exhibit quite variable biology,
ranging from indolent tumors to rapidly progressive disease that quickly leads to death, often among adolescents
and young adults. We recently reported that treatment of SDH-def GISTs with temozolomide (TMZ) resulted in
favorable responses in a small patient cohort, and these findings led to a multicenter phase II trial to investigate
the efficacy of TMZ in SDH-def GIST patients. We also developed the first and only patient-derived SDH-def
GIST cell culture biorepository, which we utilized to discover that TMZ induces expression of death receptor 5
(DR5), a TRAIL receptor. Inhibrx Inc. in La Jolla, CA has developed an entirely new therapeutic agonist that
binds to DR5 receptors, and collaboratively, we have used these together with TMZ to initiate apoptosis and
reduce cell viability in vitro. This initial finding, together with major new preliminary data we now present, suggests
that a synergistic strategy, combining DR5 agonism with TMZ, may lead to more effective treatment outcomes
for SDH-def GIST patients, and thus address this unmet medical need. The overall objective of this proposed
U01 is to unite NIH intramural and extramural SDH-def GIST clinicians and researchers with expertise in adult
and pediatric medical oncology, surgical oncology, basic and translational science, patient advocates, and an
industry partner to address two long-term goals: (1) to accurately distinguish SDH-def GIST patients who will
have indolent biology from those who will have aggressive biology; and (2) to identify and test safe, effective
therapeutic strategies for treating SDH-def GIST patients, especially those with more aggressive forms of this
cancer who will otherwise die. Supported by our preliminary data, we hypothesize that SDH-def GISTs possess
underappreciated tumor heterogeneity and hence correspondingly complex biology that will require combination
therapies to achieve disease control. By accomplishing our aims, we will better understand the biology of these
tumors and identify an improved treatment strategy for this disease. We propose to leverage our existing National
Succinate Dehydrogenase-Deficient GIST Translational Research and Clinical Trial Consortium along with
unique NIH Clinical Center resources to: (1) evaluate the safety and efficacy of TMZ with INBRX-109 (a potent
DR5 agonist) among patients with progressive SDH-def GIST in a Phase I/II clinical trial; (2) create a centralized
biobank of well-annotated SDH-def GISTs; (3) develop a network of research laboratories to develop improved
preclinical models to investigate diverse SDH-def GIST biology; and (4) develop clinical tools to predict SDH-
def GIST prognosis. Our project has the potential for immediate clinical impact to manage and treat SDH-def
GIST patients, and will provide much-needed near-term hope for these patients, their families, and caregivers.

Public health relevance
PROJECT NARRATIVE Succinate dehydrogenase (SDH) deficient subtype of gastrointestinal stromal tumor (GIST) is (1) caused either by inherited genetic or sporadic epigenetic silencing of succinate dehydrogenase (SDH) genes; (2) characterized by variable biology that ranges from indolent growth to rapidly progressive, fatal disease; and (3) associated with limited treatment options. This proposed U01 project will (1) combine our existing National Succinate Dehydrogenase-deficient GIST Translational Research and Clinical Trial Consortium with unique NIH Clinical Center resources to evaluate the efficacy of a new combinatorial treatment strategy for SDH-deficient GIST patients; (2) create a centralized biobank of well-annotated SDH-deficient GISTs; (3) develop a network of research laboratories with novel complementary preclinical models of SDH-deficient GIST biology; and (4) develop new molecular tools to predict prognosis of SDH-deficient GIST. We anticipate that these aims will test the first efficacious combination therapy for SDH-deficient GIST, create a novel resource for researchers to improve our understanding of SDH-deficient GIST heterogeneity and biology, and molecularly define risk of disease progression/metastasis that can be used to immediately improve SDH-deficient GIST patient care and well-being.